Improving parent-adolescent communication about sexual and reproductive health

PROJECT SUMMARY
Early adolescence, between the ages of 10-13, is a critical time for sexuality development. It is a period when
most young people enter puberty and have new questions about bodies, relationships, and sexual activity.
However, the majority of US adolescents enter this early adolescent period without access to the kind of
inclusive, comprehensive sex education that could help them develop the confidence and skills they need to
safely negotiate new sexual experiences. Comprehensive sex education is a well-established holistic
intervention that can help prevent sexually transmitted infections (STIs) and unintended pregnancies and
promote sexual wellbeing; a key component of this education is the role of parents. Parents can provide
adolescents with guidance and support on sexual and relationship health issues, yet many parents and
adolescents never have meaningful conversations about sex. These conversations can be anxiety-inducing, and
current solutions, such as books, websites, and training workshops, are failing to fill this gap. Many of these
solutions are difficult to implement and, more importantly, often fail to help both parents and their children to build
their communication skills. In order to make parent-adolescent conversations about sex more approachable,
Teen Health Research, Inc., is building TheTalk: a comprehensive, personalized, culturally-sensitive platform to
modernize parent-adolescent communication about sex. TheTalk will be a customizable and adaptive
conversation coach that can guide parents and their young adolescent children (ages 10-13) through difficult
conversations regarding sexual health and wellness. This is an ideal stage to educate adolescents as they are
starting puberty and becoming more curious about sexuality. Unlike most current solutions, TheTalk will use an
online, multimedia approach that is engaging to a generation of teens who are accustomed to connecting and
learning online. TheTalk will also deliver customized multimedia resources to both parents and adolescents
based on the adolescent’s age and gender and the parent’s values and biggest barriers to communication. In
this Phase I STTR project, we will build TheTalk into a Minimally Viable Product (MVP) and collect end-user
feedback on usability, communication features, and perceived value. Aim 1: We will form advisory boards of
adolescents and parents to select content for the initial platform that is inclusive, medically accurate, age-
appropriate, culturally relevant, and highly engaging. We will work with Oak City Labs to create a test-ready
version of our app that is customizable by user preference and functional across multiple web browsers. Aim 2:
We will then perform a usability and acceptability study regarding webapp UI/UX on 30 parent-adolescent dyads
and iteratively update design and content. Completion of this study will result in generation of our MVP and
provide initial feedback on design and content to de-risk future efficacy studies in a wider population. Successful
development of TheTalk has the potential to help parents and teens overcome their fears of talking about sex,
improve adolescent relationship skills, and ultimately reduce STIs and unintended pregnancy.

Public health relevance
PROJECT NARRATIVE Early adolescence, between the ages of 10-13, is a critical time for sexuality development. Parents are uniquely suited to offer age-appropriate, comprehensive sexual education to their children, but many parents struggle to do so. To solve this problem, Teen Heath Research is developing TheTalk, an app to coach parents and teens through impactful, culturally-sensitive discussions about sex with the end goal of reducing adolescent sexual risks and promoting sexual health and wellbeing.